Towards a Unified Framework for Dopamine Signaling in the Striatum

Project abstract
Animals, including humans, interact with their environment via self-generated and continuous actions that
enable them to explore and subsequently experience the positive and negative consequences of their actions.
As a result of their interactions with the environment, animals alter their future behavior, typically in a manner
that maximizes positive and minimizes negative outcomes. Furthermore, how an animal interacts with its
environment and the actions that it chooses depend on its current environment, its past experience in that
environment, as well as its internal state. Thus, the actions taken by an animal are dynamic and evolving, as
necessary for behavioral adaptation. It is thought that both the execution of actions, in particular goal-oriented
actions, and the modification of future behavior in response to the outcome of actions, depend on evolutionarily
old parts of the brain called the basal ganglia. Within the basal ganglia, cells that produce dopamine have a
profound influence on behavior, including human behavior, and their activity appears to encode for features of
the environment and animal experience that are important for directing goal-oriented behavior. Here we bring
together a team of experimental and computational neurobiologists to understand how these dopamine-
producing cells modulate behavior and basal ganglia circuitry. We will use unifying theories and models to
integrate information acquired over many classes of behavior. Completing the proposed work, including the
technical advances and biological discoveries, will provide a platform for future analyses of related circuitry and
behaviors in many species, including humans.

Public health relevance
Project Narrative We propose to understand the function of dopaminergic midbrain centers in controlling motor actions. We will study what features of experience, behavior, and action are encoded in the activity of these cells. We will study dopaminergic centers in the context of cued, self-timed, and spontaneous motor actions and interpret our results in a computational and theoretical framework.